Gastroenterology Research Training

ABSTRACT
This is a competitive renewal application for years 25-30 of a program to train postdoctoral investigators in
basic and translational gastrointestinal research. An interdisciplinary faculty of 17 established mentors and 3
mentors-in-training is drawn from the Center for Gastrointestinal Biology and Disease (P30 DK34987). Our
T32 program’s primary goal is to develop future academic and scientific leaders of gastroenterology research
by training promising MD, MD/PhD, DVM, DVM/PhD and PhD postdoctoral scientists to become independent
laboratory-based and translational investigators focused on impactful gastrointestinal topics. Our Aims are to:
1. Identify, recruit, and foster the career development of outstanding postdoctoral scientists of diverse
backgrounds committed to training and career development in gastrointestinal biomedical research.
2. Match trainee strengths and interests with complementary mentoring teams.
3. Provide intensive mentored research experience and training.
4. Teach research approaches using cutting- edge techniques that sustain independent research careers.
5. Provide career mentoring, including training on successful grant and manuscript preparation.
6. Bring together faculty and fellows through seminar series and other academic activities fostering an
interactive training community that emphasizes career development and interdisciplinary education.
7. Interface clinicians and clinician-scientists with basic investigators among both trainees and mentors to
provide broad understanding of disease pathophysiology, mechanisms and treatment.
Our GI training program has a robust pipeline of highly qualified applicants who undergo comprehensive
interdisciplinary research training and career development that prepares them well for sustained, impactful
independent research careers. In the past 10 years (since the 2010-2011 cycle, 21 of the 24 postdoctoral
trainees (88%) who have completed their T32 support are in either academic (11), government (1), or
research-intensive industry (4) positions, or are currently continuing their postdoctoral research (2) or clinical
(3) training. Fifteen of the 19 T32 trainees who have completed overall training (79%) are in research-
intensive positions. The mean publications/ trainee is 3.5 (range 0-12) by the 24 postdoctoral trainees who
have completed their T32 support in the last 10 years. Twenty/24 (83%) have at least one 1st authored peer-
reviewed publication (including reviews) and 19/24 (79%) have published at least one 1st authored peer-
reviewed research paper. Five/24 received individual F32 NRSA awards, 6 received CGIBD P30DK34987
pilot/feasibility awards and 7 obtained Career Development research funding (5 NIH K awards). Four trainees
from the past 15 years have obtained R01 grants and 3 received AGA Research Awards.

Public health relevance
PROJECT NARRATIVE This is a competitive renewal application for years 25-30 of a program to train postdoctoral investigators in basic and translational gastrointestinal research. Our T32 program’s primary goal is to develop future academic and scientific leaders of gastroenterology research by training promising MD, MD/PhD, DVM, DVM/PhD and PhD postdoctoral scientists to become independent laboratory-based and translational investigators focused on clinically relevant gastrointestinal research topics. Our training program has a robust pipeline of highly qualified applicants who undergo comprehensive interdisciplinary research training and career development that prepares them well for sustained, impactful independent research careers.